Maximizing sensitivity for ultra-low dose PET imaging

Summary
Small-animal positron emission tomography (PET) has been widely used as a powerful tool for preclinical studies
to image a wide range of biological processes in vivo. The key parameters in PET are its spatial resolution and
sensitivity that determine the ability to image and quantify radiotracers in a small region of the subject at sub-
nanomolar concentrations. However, the applications of small-animal PET have been limited in its application
by a combination of spatial resolution and more importantly, the sensitivity, which hampers the use of PET for a
range of applications including imaging of low-levels of receptor and transgene expression, imaging of
therapeutic cell circulation and fast dynamic imaging to capture cardiac dynamics.
The main goal of this proposal is to develop a very high sensitivity total-body small-animal PET scanner
dedicated for ultra-low dose and fast dynamic applications for imaging mouse/rat disease models. The proposed
PET scanner will have 72 depth-of-interaction (DOI) detector modules arranged in 6 rings, with a ring diameter
of 160 mm and an axial length of 242 mm. The geometry of the proposed PET scanner is designed to cover the
whole body of the mouse/rat and to obtain high sensitivity and high resolution across the entire body.
Dual-ended readout detectors based on SiPMs coupled to both ends of bismuth germanate (BGO) will be used
to extract DOI information to maintain high and uniform spatial resolution across the whole field of view (FOV).
BGO is chosen due to its high stopping power, high photoelectric ratio, low cost and the most importantly its
negligible background radiation (which can significantly reduce the background events to benefit ultra-low dose
imaging). While lutetium-based scintillators have many attractive properties, a major limitation is the presence of
intrinsic background radiation, which is a significant barrier for ultra-low dose imaging.
Dedicated data acquisition electronics will be designed for the proposed scanner. Specifically, a novel analog
signal multiplexing readout method using Schottky diodes to block the noise of SiPMs with negligible signals will
be used to simplify the readout electronics and to improve the spatial resolution and the timing resolution, and a
shared-photodetector readout method will be used to identify all the crystals.
The outcome of this proposal will be a PET scanner will have a sensitivity >50% at the center of the FOV and a
sensitivity > 40% within the central 100 mm of the axial FOV. The resolution is predicted to be ~ 1 mm at the
center of the FOV and better than 1.5 mm across the entire FOV. The sensitivity is more than 4x better than
currently available small-animal PET scanners. It can potentially promote the use of total-body small-animal PET
for monitoring biological processes that result in very low source activities and expand the range of applications
for this powerful, non-invasive and translational imaging modality in preclinical applications. The PET scanner
developed in this proposal is also MRI-compatible and will support eventual integration inside an MRI scanner
for hybrid PET/MRI imaging.

Public health relevance
Narrative Positron emission tomography (PET) is a molecular imaging technique widely used in clinical diagnostics, and in clinical and preclinical research. However, the performance of current PET systems is far from reaching the theoretical limit in terms of spatial resolution and sensitivity, which limit its application in ultra-low dose imaging and fast dynamic imaging, such as imaging of low-levels of receptors, tracking of therapeutic cells and imaging of cardiac contraction. We propose to develop a small-animal PET scanner with a sensitivity higher than 40%, a spatial resolution better than 1.5 mm3 across the mouse/rat body, and using detector materials with no intrinsic background, to enable ultra-low dose preclinical imaging and fast dynamic imaging in mice/rats. The improved performance will promote the use of total-body small-animal PET imaging for monitoring biological processes that result in very low source activities and expand the range of applications for this powerful, non-invasive and translational imaging modality in preclinical applications.